Optimal Use of Enhanced Barrier Precautions in Nursing Homes to Prevent the Transmission of MDROs

Enhanced barrier precautions (EBP) is a new type of transmission-based isolation precautions developed
specifically for the nursing home environment. EBP refer to the use of gown and gloves during high-contact
nursing home resident care activities. The CDC recommends EBP for residents with a history of multi-drug
resistant organism (MDRO) colonization or with chronic wounds or devices regardless of MDRO colonization to
interrupt the transmission of MDRO. The current CDC guidance for EBP places too many nursing home
residents on EBP. We need to better risk stratify residents for EBP to minimize the burden on nursing homes
and their staff while preventing patient to patient MDRO transmission. The large trials that could identify the
highest risk populations are costly and now unlikely to be performed. Because of this, we should define the
indications for EBP based on the risk of transmission estimated by the quantity of MDRO which contaminate
HCP gown and gloves after routine care. Nursing homes have different levels of care with short stay residents,
long stay residents and, in a small minority of nursing homes, residents who require chronic ventilatory support
(aka chronic ventilator residents). Our preliminary data suggests that chronic ventilator residents are a high-risk
population for MDRO transmission and should be targeted for EBP regardless of known MDRO colonization.
As an example, 9 of 25 enrolled chronic ventilator residents show that HCP gloves and gowns can be
contaminated with high quantities (>300 CFU per gown or glove swab) of carbapenem-resistant Acinetobacter
baumannii. A critical limitation of our current study is that we have no control group of non-ventilated nursing
home residents using similar methodology. To fill this gap, we propose to enroll an additional 50 short stay and
long stay residents who are MDRO colonized to provide a comparison group to the MDRO colonized chronic
ventilator unit residents. Our aims are: 1) to quantify the risk of MDRO transmission from resident care
activities in 50 MDRO colonized short and long stay residents of multiple community-based nursing homes and
2) compare that to the current study of 50 MDRO colonized chronic ventilator residents. The results of this R21
will assess the feasibility of using the relative risk of MDRO transmission from quantitative cultures of gowns
and gloves after resident care activities from MDRO colonized chronic ventilator residents, long stay residents
and short stay residents. On a larger and more generalizable population, this approach could provide the CDC
with the relative effectiveness of implementing EBP using different indications having a major impact on how
our nursing homes use EBP. The expected outcome of this grant is to determine whether chronic ventilator
residents are the highest priority population for which EBP should be applied in nursing homes.

Public health relevance
Narrative: Approximately 1.3 million people in the United States reside in a nursing home. Colonization with antibiotic resistant bacteria is common in nursing home residents. This project aims to develop a framework for how healthcare personnel in nursing homes should use gowns and gloves during care to prevent the transmission of antibiotic resistant bacteria between residents.